Lung Myofibroblast De-Differentiation and Fibrosis Resolution Depend on cAMP-mediated Inhibition of HuR.

Project Summary/Abstract:
This proposal describes a five-year research and career development plan intended to support the applicant’s
progression to an independent physician-scientist investigating mechanisms of lung myofibroblast (MF) de-
differentiation/clearance and pulmonary fibrosis resolution.
Research Plan: Idiopathic pulmonary fibrosis (IPF) is the deadliest fibrotic lung disease, affecting millions of
individuals worldwide, with limited treatment options that fail to reverse established fibrosis. MFs are the
ultimate effector cells of IPF whose persistence following wound repair – a consequence of their apoptosis
resistance – leads to progressive lung scarring and stiffness, distorting tissue architecture and impairing gas
exchange. Clearance of lung MFs – through their phenotypic de-differentiation and restoration of apoptosis
sensitivity – has the potential to resolve fibrosis. The applicant has discovered that lung MF de-differentiation
can proceed via distinct transitional phenotypes and that post-transcriptional regulation of mRNAs is crucial to
this process. In this proposal, he will investigate the role of the endogenous anti-fibrotic brake cyclic adenosine
monophosphate (cAMP) and its regulation of the master post-transcriptional regulator human antigen R (HuR)
in MF de-differentiation and fibrosis resolution.
Applicant and Training Plan: The applicant holds an MD degree and has completed clinical training in Internal
Medicine, Pulmonary, and Critical Care Medicine. During his fellowship and prior research endeavors, he has
gained experience with in vitro systems and basic lab techniques in fibroblast biology. As part of his career
development, the applicant will participate in mentored research designed to develop new knowledge and
proficiency in RNA biology, CRISPR/Cas9 techniques, immunofluorescence microscopy, bioinformatics, and
use of novel transgenic mice for in vivo modeling and investigation of pulmonary fibrosis. Acquiring these new
skills and experiences will greatly facilitate his development into an independent investigator studying the
mechanisms by which MFs can be de-differentiated and cleared, enabling strategies to promote fibrosis
resolution. Training in these areas will be acquired under the guidance of his experienced mentoring team, and
through participation in seminars, lab meetings, coursework, workshops, and national meetings. He will also
receive training in grant writing and responsible conduct of research. The outstanding institutional research
environment provides the applicant abundant opportunities for interaction with investigators in RNA and
molecular biology, pulmonary and extra-pulmonary fibrosis, as well as with basic and translational scientists.
Available facilities for advanced imaging, RNA sequencing, and transgenic animal modeling will be utilized.
This application will thus enable a well-trained and committed junior investigator to develop an independent
career in the investigation of cellular and molecular mechanisms that can be translated into the resolution of
established pulmonary fibrosis – the holy grail of research in this field and an enormous unmet clinical need.

Public health relevance
Project Narrative Idiopathic pulmonary fibrosis (IPF) is a common and deadly scarring lung disease for which there is no cure. The development and progression of IPF proceeds when myofibroblasts – scar forming and contractile cells that differentiate from fibroblasts – fail to de-differentiate following lung injury. This proposal seeks to investigate the mechanisms by which myofibroblasts can be de-differentiated and cleared – thereby enabling fibrosis resolution – as well as to support the career development of a promising and committed physician scientist.